Inter-membrane lipid signaling for preserving Gram-negative outer membrane integrity and antibiotic resistance

ABSTRACT
The alarming increase in antibiotic-resistant bacterial infections is a looming public health crisis. Gram-negative
bacteria, including Escherichia coli and Pseudomonas aeruginosa, are leading causes of mortality attributed to
antibiotic resistant infections. These bacteria build an outer membrane (OM) around their cell that acts as a
shield, blocking the entry of many antibiotics and conferring potent intrinsic antibiotic resistance. Key to the OM’s
barrier function is the packing of lipopolysaccharide (LPS) molecules into the surface-exposed outer leaflet of
the OM bilayer. Phospholipids (PLs) then make up the OM inner leaflet. An LPS deficit in the OM allows PLs to
mislocalize to the surface (to fill the void) and this weakens the OM. OM lipid asymmetry is critical for Gram-
negative survival, virulence, and antibiotic resistance. Accordingly, bacteria employ active measures to maintain
lipid asymmetry. We uncovered evidence for a novel inter-membrane lipid signaling mechanism by which E. coli
can sense LPS deficiency in the OM and trigger increased LPS synthesis inside the cell so that OM lipid
asymmetry can be restored. Signaling originates from an OM phospholipase (PldA) that degrades mislocalized
PLs; lipid products from this reaction are internalized and notify the cell of the LPS deficiency in the OM. Our
preliminary data suggest that PldA plays a key homeostatic role. Deleting pldA is lethal in mutant strains with
slow transport of LPS to the OM. Moreover, PldA activity can potently resist antibiotic inhibition of LPS synthesis.
Recent novel antibiotic discovery efforts have focused on disrupting LPS synthesis and transport to the OM. Our
data forewarn that PldA may enable resistance to such drugs in the pre-clinical pipeline. However, our data also
offer hope that interfering with PldA lipid signaling may potentiate the action of these emerging novel antibiotics.
We aim to test the role of PldA in protecting E. coli against LPS synthesis and transport defects induced
genetically or with antibiotic inhibitors. Our goal is to characterize the PldA lipid signaling pathway and unravel
the steps leading to increased LPS production. We also aim to explore the conservation of inter-membrane lipid
signaling by examining the newly discovered OM phospholipase of P. aeruginosa and assessing if it too can help
counteract LPS deficits in the OM. Our study will establish a new inter-membrane lipid signaling paradigm in two
important pathogens and will reveal new insights into how OM lipid asymmetry is continuously sensed and, if
broken, rapidly repaired so that integrity of the OM antibiotic barrier can be continuously preserved.

Public health relevance
PROJECT NARRATIVE Gram-negative bacteria produce an outer membrane that shields them from antibiotics, limiting the clinical tools available to treat infections. To be an effective shield, the outer membrane’s lipid content is asymmetrically distributed, so that lipopolysaccharide at the cell surface can block antibiotic entry. We will dissect a novel lipid- based signaling mechanism that Gram-negatives use to sense and repair disruption of lipid asymmetry, ensuring their OM remains a formidable barrier.